Paracrine regulation of angiogenesis through integrin crosstalk

DESCRIPTION (provided by applicant): Previous work from our group has shown that integrin α3β1 plays a critical role in the secretion of paracrine factors that promote both wound and tumor angiogenesis, highlighting the importance of integrin-mediated paracrine signaling from the epidermis to endothelial cells in the wound bed or tumor microenvironment. Unlike tumor angiogenesis, wound angiogenesis ultimately returns to a normalized state. Understanding how wound angiogenesis resolves may reveal aberrant processes in the tumor setting which could be exploited for targeted therapy. A major barrier to developing effective integrin-targeting therapies has been failure to identify key integrin-ECM interactions that work in a coordinated fashion to regulate tumor angiogenesis and other tumorigenic functions. The proposed work will address this knowledge gap by testing combinatorial roles for two integrins, α3β1 and α9β1. Both of these integrins are up-regulated in progressing squamous cell carcinoma (SCC) and in the activated wound epidermis. While it is known that these two integrins also exert distinct influences on keratinocyte function, preliminary data presented in this proposal clearly suggest a model in which many functions guided by α3β1 are tempered by α9β1. Furthermore, their ECM ligands are deposited into the provisional wound matrix at different times, suggesting temporal regulation of α3β1 and α9β1 in the wound setting. Indeed, while the α3β1 ligand, laminin-332 (LN-332), is deposited by activated keratinocytes immediately upon wounding, α9β1 ligand, cellular fibronectin (cFN), appears later in the provisional wound matrix. Upon expanding this study to an in vivo system, we observed that angiogenesis is compromised in wounds in which keratinocytes lack α3β1, but is aberrantly prolonged in wounds in which keratinocytes lack α9β1, suggesting that α9β1 acts as a brake on α3β1-dependent processes. Based on these preliminary data, we propose the novel hypothesis that α9β1 suppresses α3β1-dependent migration, as well as paracrine functions of the epidermis that promote angiogenesis. Furthermore, our model predicts that modulation of α3β1 function by α9β1 is regulated in a temporal manner, potentially by binding specific α9β1 ligands that are temporally or spatially regulated in wounds, and that such modulation is critical to regulating wound angiogenesis. Finally, we propose that this novel mode of integrin crosstalk regulates tumor invasion and angiogenesis as well. To test our hypothesis, we propose two Specific Aims: Aim 1: To determine mechanistically how α9β1 mediates cross-suppressive regulation of α3β1-dependent cellular functions and gene expression, in vitro; and Aim 2: To identify in vivo regulation of angiogenesis and/or tumorigenesis by α9β1-mediated cross-suppression of α3β1. Results from this work will improve our understanding of the roles that integrins play in promoting angiogenesis in both wounds and tumors, and it may facilitate the development of novel integrin-targeting therapeutics to inhibit cancer progression.

Public health relevance
PUBLIC HEALTH RELEVANCE: This research project addresses the combinatorial role of epidermal integrins in mediating paracrine functions that control angiogenesis in both the wound and tumor microenvironments. Specifically, I will investigate molecular mechanisms through which α9β1 exerts cross-suppressive regulation over α3β1 in vitro, and I will determine whether α3β1 and α9β1 coordinately regulate cell functions that promote cell motility, invasion, and angiogenesis in vivo. Results from this work will improve our understanding of the roles that integrins play in promoting angiogenesis in both wounds and tumors, and it may facilitate the development of novel integrin-targeting therapeutics to inhibit cancer progression.